Summer Research Experience in Neurobiology at the Jackson Laboratory

PROJECT SUMMARY/ABSTRACT
The Jackson Laboratory (JAX) proposes to renew the existing Summer Research Experience in Neurobiology
to continue supporting a focused neurobiology cohort within the existing JAX Summer Student Program, an
internationally recognized research education program for undergraduates. Under the proposed renewal, six
undergraduate students will conduct neurobiology research in the labs of 11 NIH-funded neuroscientists who
lead cutting-edge, collaborative research programs in Alzheimer’s disease, peripheral neuropathies, motor
neuron degeneration, synaptic development, retinal disease, epilepsy, addiction, Rett syndrome, stroke and
sensory disorders. The 10-week residential internship will provide each participant with a summer salary plus
funds to support research supplies and travel to national meetings to present their findings. The proposed
program will offer an intense research internship in neurobiology with a focus on the laboratory mouse as an
investigative tool to probe the basic mechanisms of human biology and disease. Students will be integrated into
their mentor’s laboratory team and will collaborate with their mentor on experimental design and result
interpretation during regular meetings. As the summer progresses, students will gain more independence in
managing their day-to-day work of conducting experiments alongside their mentors. The defined research
education curriculum will include asynchronous online learning modules, as well as workshops on the
programming language R, animal care and use procedures, ethical conduct of research within historical and
modern scientific contexts, and science communication. JAX institutional commitment includes student access
to intellectual and research resources such as on-campus courses and conferences, state-of-the-art
instrumentation and bioinformatics databases, dedicated program direction by JAX Genomic Education, and a
staffed on-campus Living Learning Community. The neurobiology cohort will join the Summer Student Program,
which is supported by institutional funds, private foundations, and federal grants and has well-established
administrative procedures for recruitment and selection, mentor training and support, and program design,
management, and evaluation. The program will identify participants, including students from underrepresented
groups in biomedicine, through national recruitment efforts and focused outreach to minority-serving institutions.
JAX offers a stimulating environment in which curious, motivated, talented students from diverse backgrounds
can learn the fundamentals of scientific inquiry, contribute to real research progress, and make great strides in
intellectual and personal growth as researchers.

Public health relevance
PROJECT NARRATIVE A trained and diverse biomedical workforce requires the support of comprehensive educational programs, including those designed to expose students to biomedical research, reinforce their intent to graduate with a science degree and prepare them for graduate studies leading to a career in science. The proposed Summer Research Experience in Neurobiology will provide opportunities for students to expand their knowledge, technical skills, scientific thinking, and problem-solving skills while contributing to cutting-edge neurobiology research. Through this experience, students will refine their career goals and aspirations as they increase their self- confidence in and out of the laboratory and grow in their ability to see themselves as researchers.